DNA Nanostructures as siRNA Delivery Vehicles for Alzheimer's Therapy

PROJECT SUMMARY
Alzheimer’s disease (AD) is the most common age-related neurodegenerative disorder, characterized by
progressive deterioration of cognitive capacity. Currently available treatments for AD are symptomatic agents
that aim to improve cognitive and behavioral symptoms without altering the underlying course of the disease or
slowing disease progression. Thus, there is a necessity for disease-modifying treatment strategies for AD that
can block or modify the molecular pathological steps leading to neurodegeneration. RNA interference is one
such strategy that has been actively pursued for selective knockdown of AD target genes, but typically used viral
vectors have preparation and safety concerns.
We propose a new DNA nanotechnology approach to overcome these issues. DNA nanotechnology offers near-
atomic control over building shapes and structures, eliminating heterogeneity in size of drug carriers. DNA can
be functionalized with additional chemical groups that allow controllable attachment of drug molecules and
protect the drug against biological degradation. Since DNA is a biological material, DNA nanostructures elicit
minimal immune response when used in drug delivery, are non-toxic, biocompatible and biodegradable. Further,
DNA nanostructures can enter cells without the need for a transfection agent. Our approach will use DNA
polyhedra as model structures for RNA interference based treatment of AD. Specifically, we will: (1) develop
DNA polyhedra with controllable attachment of small interfering RNAs (siRNAs) and incorporate 2'-O-methyl
strands to enhance biostability in physiological environments, and (2) establish viability of DNA nanostructure-
based drug delivery in human induced pluripotent stem cell (iPSC) derived AD model cell lines.
Our proposal brings together an interdisciplinary team comprising a diverse group of researchers in chemistry,
biology, and neurological disorders to provide a novel approach for RNAi treatment of AD. The proposed strategy
has a number of advantages including (i) precise drug loading and quantification, (ii) biocompatibility and
biodegradability, (iii) low dosage with high efficacy, and (iv) enhanced biostability to withstand physiological
conditions and complex biofluids. We anticipate that our approach will provide a robust proof of concept for viable
siRNA delivery by DNA nanostructures with great future potential for clinical treatment of AD.

Public health relevance
NARRATIVE Disease-modifying treatment strategies with minimal side effects and toxicity are of significant interest in treating Alzheimer’s disease, but it is often difficult to controllably load drugs to delivery systems that are biocompatible and biodegradable. We use DNA nanotechnology to create size-defined siRNA delivery vehicles for AD therapy based on RNA interference.